Core D - Recombinant Antibody Core

CORE SUMMARY
Core D is a new core in this renewal that will be used by all three Projects. Use of recombinant antibodies (rAbs)
and novel bispecifics allows for precise control over and targeting of inhibitory receptors PD1 and LAG3 and
provides invaluable insights into their synergy and roles in orchestrating immune responses across diverse cell
types and diseases. Common rAbs and bispecifics will also facilitate comparison across the all Projects.
AIM 1: To provide core antibody reagents. Core D will use a rigorous and efficient process to generate
murinized IgG1-based rAbs specific for PD1 and LAG3 along with a PD1:LAG3 bispecific rAb, plus controls, for
all Projects. Core D is optimizing a version of the bispecific that will selectively bind to only PD1+LAG3+ T cells
using scFv yeast display affinity optimization system.
AIM 2: To provide novel antibody tool reagents. Core D has the capacity and capability to generate
innovative, high-risk/high-reward rAbs, bispecifics, and ADCs as needed for the Projects, with careful
consideration mediated through Core A. Initially, we plan to develop 2 new rAb-based tools outlined in P2 and
P3: [i] a cytolytic version of the PD1:LAG3 bispecific, achieved by mutating the IgG1 Fc or using an IgG1-IgA Fc
fusion to broaden susceptibility to Fc receptor binding; and [ii] an antibody–drug conjugate (ADC) with IFNγ
and/or IL2 attached to a PD1:LAG3 mono- and bi-specifics. These new tools will be generated, validated, and
shipped to the Projects by Core D.
IR-PPG Interactions: In addition to supporting all three Projects, Core D will also work with Core A to provide
data access, facilitate production, monitor budget and core usage, and facilitate shipping to outside investigators
once reagents are published, and Core C to consider additional, novel rAb tools.